Drivers of strain-specific and strain-transcendent antimalarial immunity in childhood

Project Summary/Abstract
Despite recent gains, the burden of malaria caused by P. falciparum (Pf) in sub-Saharan Africa remains
unacceptably high. Vaccines offer the greatest potential to produce sustained protection against malaria, but
the only licensed vaccine for malaria is short lived and only modestly effective. Decades of research have been
unable to produce a feasible vaccine which approaches the efficacy of naturally acquired immunity (NAI),
which provides nearly complete protection against symptomatic disease in adults in many endemic areas. NAI
to malaria is complex slow to develop. Antibodies are key effectors of NAI, and eventually overcome the high
degree of genetic diversity evolved by Pf antigens important in host-parasite interactions. This diversity may
underlie the slow development of NAI and relative inefficacy of current vaccines. While it is loosely understood
that increasing cumulative exposure to Pf leads to greater immunity, fundamental questions remain
unanswered. The aims of this project are (1) to determine the effect of the number, timing, and genetic
composition of blood stage Pf infections on NAI in childhood; and (2) to determine the effect of the number,
timing, and genetic composition of exposure to Pf in childhood on the antibody repertoire, and how antibody
responses relate to immunity. We are in a unique position to achieve these aims by leveraging an extensive
set of existing samples and data from multiple intensively followed early childhood cohorts in Uganda along
with a team of experienced collaborators with expertise in malaria epidemiology, statistics, genomics, and
immunology. In Aim 1, we will initially perform whole genome sequencing on a subset of Pf infections in our
cohorts to systematically identify antigenic variants under potential selection. These antigens, along with others
identified from existing data, will be deep sequenced from all infected time points using highly multiplexed deep
sequencing. We will quantify anti-parasite and anti-disease immunity using detailed clinical data, and combine
these data to test 3 fundamental hypotheses regarding the relationship between exposure and immunity. In
Aim 2, we will longitudinally evaluate antibody responses to Pf in our cohorts using ultra-high throughput long
peptide arrays, targeting the entire genome including all identified antigenic variants. We will identify
sequences of key antigens from these experiments and from Aim 1, and further evaluate antibody responses
using custom protein arrays with experimental validation using functional assays. Using these data, we will test
an additional 3 hypotheses. At the conclusion of this project, we will have identified fundamental factors driving
the development of NAI, including the role of strain-specific vs. transcendent immunity and the identification of
antigenic variants most associated with immunity and thus most appropriate for inclusion in a malaria vaccine.

Public health relevance
Project Narrative Vaccines offer the greatest potential tool to provide protection against malaria and to maintain gains in malaria control and ultimately move to elimination. However, a lack of understanding of how immunity naturally develops in children living in high burden areas has severely limited our ability to develop an effective malaria vaccine. The central theme of this proposal will be to improve our understanding of factors driving the development of naturally acquired immunity in Ugandan children by studying infecting parasites and the host response in detail as immunity develops.